Immunity and Infectious Disease

Project Summary/Abstract:
This application is a resubmission of a renewal for a pre-doctoral training program in Immunity and Infectious
Disease at The Rockefeller University, an institution with a rich history in these areas. The Immunity and
Infectious Disease Training Program is specifically designed for education in immunology and infectious
disease, and incorporates required coursework, rotations, and extensive research opportunities. The 18 faculty
trainers are accomplished scientists, including 6 members of the US National Academy of Sciences, with a
shared interest and experience in graduate education. The faculty has expertise in a very broad range of
immunology and infectious disease, and the program encourages trainees to perform collaborative work in
various areas with different faculty.
We propose to support 6 pre-doctoral trainees during years 2-4 of graduate study. The applicant pool is
outstanding, including a large number of students with accomplished undergraduate records, extensive
research experience and a strong interest in immunology and infectious disease. Trainees would be mentored
by the Program Director; a Program Advisory Committee of selected faculty for general curriculum and
research advice; and a Faculty Advisory Committee, specifically designed for each trainee to provide detailed
experimental guidance. An External Advisory Committee will evaluate the effectiveness of the program and
provide advice on new initiatives.
Finally, the University provides extensive support for the graduate program in general, which benefits the
Immunity and Infectious Disease training program. The confluence of these attributes defines a specific
training program that would equip trainees with the educational background, analytical abilities, and
experimental expertise to forge future advances in immunology and infectious disease.

Public health relevance
Project Narrative: This training grant supports research and education that is directly relevant to public health, including clinically relevant coursework and research opportunities in areas including tumor immunology, inflammatory bowel diseases, HIV, Hepatitis C and tuberculosis.